KANSAS U COBRE: TRANSGENIC & GENOTYPING CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The gene-modified mouse has become a standard and indispensable tool for investigating the function of genes in vivo. Although the modified mouse is common, the techniques employed for its generation require skill and specialized equipment. It is far more cost- and time-effective to centralize both the equipment and skill into a core, shared, research support facility, as has been done here, rather than equipping and training individual laboratories. By centralizing operations, the gene-modified mouse is available as a research tool to all investigators. The Transgenic and Gene-Targeting Facility provides services to COBRE investigators that include generation of transgenic mice by pronuclear injection, generation of chimeric mice by blastocyst injection, targeting of embryonic stem cells by electroporation, cryopreservation of sperm from gene-modified mice and genotyping of gene-modified mouse litters. All of these services have been requested by and performed for members of the COBRE.